Mid-America Regional Coordinating Center (MARCC)

Abstract
Subacute neurological changes due to COVID-19 (six months – one year post infection) remain poorly
characterized. This may be increasingly important as previous pandemics, e.g. 1918 influenza, have
demonstrated that neurological conditions (e.g. delirium, encephalitis, and neurodegenerative
conditions) are more prevalent during the subacute and chronic (> one year) phases. Anecdotal
accounts of COVID-19 positive patients have suggested that “brain fog” and fatigue develop during the
subacute period, especially in more severely affected individuals. This proposal leverages two existing
cohorts of patients enrolled at Barnes-Jewish Hospital and the Infectious Disease Clinical Research Unit
at Washington University in Saint Louis. An acute cohort consists of participants who present to the
emergency room with symptoms consistent with COVID-19 and who are followed throughout their
hospital stay, if admitted, and post infection in the outpatient setting. A second cohort, a convalescent
cohort, is enrolling confirmed COVID-19 positive participants who were primarily asymptomatic or
mildly symptomatic and who are followed post infection in the outpatient setting. This proposal has
three aims. Aim 1 will evaluate subacute cognitive changes observed six months post infection in COVID-
19 positive patients. Aim 2 will evaluate subacute neuroimaging changes observed six months post
infection in COVID-19 positive patients. Aim 3 will evaluate subacute multi-omic blood changes observed
six months post infection in COVID-19 positive patients. Overall, we hypothesize that COVID-19 positive
patients with more severe symptoms (intensive care unit (ICU) admission) will have more cognitive
deficits, neuroimaging changes, and blood transcriptomic, proteomic, metabolomic, and lipidomic
abnormalities at six months post infection compared to COVID-19 positive patients who were
hospitalized or who were asymptomatic. This proposal is therefore a time sensitive opportunity to
characterize the neurological changes seen at six months post infection within 100 patients from these
diverse cohorts of COVID-19 positive individuals.

Public health relevance
Narrative Subacute neurological changes due to COVID-19 (six months – one year post infection) remain poorly characterized. Anecdotal accounts of COVID-19 positive patients have suggested that “brain fog” and fatigue develop during the subacute period, especially in more severely affected individuals. This time sensitive proposal leverages two existing cohorts (an acute and a convalescent) of COVID-19 patients enrolled at Barnes-Jewish Hospital and the Infectious Disease Clinical Research Unit at Washington University in Saint Louis. We hypothesize that COVID-19 positive patients with more severe symptoms (intensive care unit (ICU) admission) will have more cognitive deficits, neuroimaging changes, and blood transcriptomic, proteomic, metabolomic, and lipidomic abnormalities at six months post infection compared to COVID-19 positive patients who were hospitalized or who were asymptomatic.